NIH - ONC Cancer Domain Collab

Due to gaps in cancer data collection standards across health systems, there is a need to prioritize use cases and obtain consensus to develop a cancer minimum, common, real-world data dataset for interoperable data exchange. Currently, cancer data is collected from various sources including laboratories, electronic health records, registries, encounter databases, Medicare, Medicaid, and other sources. Identifying and standardizing core data elements for oncology can facilitate clinicians, researchers, and public health officials leveraging those data elements for interoperable data exchange. In addition, standardized data collection will support the HHS Moonshot data strategy that is aligned with the White House Cancer Cabinet’s Moonshot Data & Innovation Task Force.